EARLY EVENTS IN CHEMICALLY INDUCED RAT HEPATOCARCINOGENESIS

The project was initiated to study the sequence of events during chemically induced neoplasia using the rodent hepatoma model in combination with quantitative two-dimensional gel electrophoresis (2D-PAGE). Results obtained to date include: (1) analysis of polypeptide differences between normal rat liver and preneoplastic and neoplastic nodules generated using either the Solt-Farber regimen ("resistant hepatocyte" model) or via feeding the nongenotoxic inducer of peroxisome proliferation, ciprofibrate, revealed few qualitative but numerous quantitative polypeptide differences; (2) polypeptide expression in individual preneoplastic and neoplastic nodules induced via the Solt-Farber protocol or with ciprofibrate was very similar, suggesting a marked "homogeneity" rather than "heterogeneity" of polypeptide expression among the early lesions; (3) all Solt-Farber generated nodules stained strongly both for gamma-gutamyltranspeptidase (GGT) activity and for the placental form of glutathione-S-transferase (GST-P), while in the ciprofibrate induced nodules the expression of GGT and s GST-P was not significantly different than control liver levels; (4) four qualitative polypeptide differnces were noted in Solt-Farber-induced nodules as compared to normal liver. Two of these, polypeptides B (pI 6.25/41 kDa) and C (pI 6.75/24 kDa) were expressed in both ciprofibrate-induced and Solt-Farber-generated preneoplastic and neoplastic nodules. In addition five membrane-associated (5.25/59 kDa, 5/30/33 kDa, 5.25/27 kDa, 6.82/23.5 kDa, and 6.75/21 kDa) and four cytosolic polypeptides (6.20/45 kDa, 5/85/36 kDa, 5.06/34 kDa, 6.00/24 kDa) were coordinately expressed in both preneoplassic and neoplastic nodules from both ciprofibrate and Solt-Farber hepatocarcinogenesis models.